Quantitative imaging and molecular data modeling for brain tumor recurrence and progression analysis

Project Summary/Abstract
The overall prognosis for Glioblastoma Multiforme (GBM) brain tumors is extremely poor with a median
survival of about one year from diagnosis and five-year survival rates of only 6.9%. Multiple biological
characteristics contribute to the lethality of GBM including rapid, uncontrolled proliferation throughout the
restricted cranial space supported by their pro-angiogenic nature and ability to rapidly develop therapeutic
resistance resulting in tumor recurrence (TR). Identification of early TR is complicated by chemoradiation induced
toxicity which can present initially as pseudo-progression and later as radiation necrosis (RN) condition that
occurs in 25% of all GBM. Currently, invasive stereotactic brain biopsy at the site of suspicion remains the only
resort for TR confirmation.
This proposed renewal study will develop novel computational models and AI methods for analyzing brain
TR, radiation necrosis (RN) and postoperative rapid early progression (REP); and to rigorously validate the
models using both in-house and public domain patient data in collaboration with the ReSPOND consortium. This
goal will be accomplished via the following aims: (1) Multi-center multimodal patient data collection, data
harmonization, and robust TR, edema and RN volume segmentation and tracking; (2) Co-analysis of imaging
and molecular features for TR and progression analysis; (3) Explainable AI modeling with uncertainty analysis
to understand TR and progression; and (4) Evaluation and cross-validation of the proposed methods. The
proposed co-analysis of radiomics, proteomics, and histopathology data is expected to enable robust TR,
progression and REP analysis that may be critical to stratification of aggressive versus non-aggressive brain
tumors for patients, with the potential for targeted therapy transcending the current limitations of the one-size-
fits-all radiation treatment planning paradigm.
In our parent R01 project, we made considerable progress in: (i) addressing critical barriers related to brain
tumor volume segmentation, tumor growth tracking, glioma diagnosis and grading; (ii) GBM patient survival
prediction using multi-modal radiology, molecular and histopathology patient data; (iii) molecular prediction of
diffuse low-grade glioma using advanced radiomics features; and (iv) prediction of low-grade glioma progression
using radiomics features. Recently, we showed the feasibility of multiresolution radiomics texture features to
discriminate TR from RN. Very recently, our pilot study showed the feasibility of quantitative co-analysis of
radiomics, proteomic and clinical patient data for REP and patient survivability prediction. Furthermore, we have
been consistently ranked among the top teams in Global Challenges on Brain Tumor Segmentation (BRaTS),
Brain Ischemic Segmentation, and Patient Survivability Prediction since 2013.
These advances will be foundational in achieving the aims of this proposed study.

Public health relevance
Project Narrative This study will develop novel computational models and AI methods for postoperative brain tumor recurrence (TR), radiation necrosis (RN) and rapid early progression (REP) analysis; and to rigorously validate the models using both in-house and public domain patient data. The proposed co-analysis of radiomics, proteomics and histopathology data is expected to enable robust TR, progression and REP analysis that may be critical to stratification of aggressive versus non-aggressive brain tumors for patients, with the potential for targeted therapy transcending the current limitations of the one-size-fits-all radiation treatment planning paradigm.